Molecular anatomy resources for postembryonic zebrafish

PROJECT SUMMARY
The zebraﬁsh is a widely used biomedical model organism and has been studied extensively at early stages.
Current research efforts focus increasingly on later stages that are relevant to understanding fundamental as-
pects of vertebrate development as well as human disease, birth defects and regenerative potential. This
project will provide a resource to facilitate such studies by identifying molecular markers for speciﬁc cell types
present at late stages, and mapping these markers and the cells they represent within the developing anatomy
of the larval ﬁsh. Candidate markers and cell types will be identiﬁed using unbiased single cell transcriptomic
approaches, and anatomical mapping will be accomplished using histological and imaging approaches, all of
which are routine for this laboratory. These resources will enable efforts by the community of investigators us-
ing zebraﬁsh for biomedical research, and will provide opportunities to further exploit this system for under-
standing and promoting human health.

Public health relevance
PROJECT NARRATIVE Elucidating cellular and molecular mechanisms of development and disease require an understanding of the tissue and organ level contexts in which these mechanisms operate. This project seeks to generate an impor- tant resource to provide such context for zebraﬁsh at postembryonic stages, by documenting the spatial distri- butions of diverse cell types through larval stages using molecular markers to be obtained using unbiased, sin- gle-cell transcriptomic approaches.